Strategies and Consequences of Polymicrobial Nasal Colonization

PROJECT SUMMARY
The upper respiratory tract is colonized by a complex and dynamic community of commensal bacteria and
opportunistic pathogens. As colonization is frequently a prerequisite for subsequent respiratory infection, this
resident flora represents a critical reservoir for bacterial pathogens responsible for sinusitis, acute otitis media,
and pneumonia. Among the leading agents of community-acquired pneumonia are Streptococcus pneumoniae,
Haemophilus influenzae, Moraxella catarrhalis, and Staphylococcus aureus, all of which are highly effective in
colonizing the upper respiratory tract of asymptomatic individuals. Colonization of the respiratory tract is often
polymicrobial with intense competition for limited nutritional resources, resulting in both synergistic and
antagonistic interactions between or within species. While our understanding of the bacterial and host factors
contributing to colonization of the upper respiratory tract has advanced considerably, a key aspect that remains
unresolved is an understanding of how polymicrobial interactions within the respiratory tract impact a pathogen’s
ability to colonize and cause infection. In my preliminary data, I demonstrate that S. pneumoniae undergoes
extensive transcriptional reprogramming upon co-culture with other respiratory pathogens. In addition to
identifying interactions between bacterial species, few models have determined the impact of interspecies
competition on subsequent host responses to a particular pathogen. A key gap in advancing this field has been
the lack of effective murine models of co-colonization, preventing detailed immunological and biological
characterization. I have developed a novel murine co-colonization model that effectively recapitulates many
of the published clinical observations. Furthermore, I demonstrate that in vivo co-colonization can dramatically
impact whether protective capacity is generated following colonization, suggesting a critical link to host-mediated
immunity. My overall goals are to 1) leverage functional genomics methods to determine how bacterial virulence
networks are altered in the context of complex infectious colonization models, and 2) determine the effect of
these colonization networks on cellular host responses following colonization through profiling of host mucosal
responses. In Aim 1 I will utilize a functional genomics strategy to identify pathways utilized by Streptococcus
pneumoniae that are operative during interspecies competition, which has not been attempted in the context
of a polymicrobial colonization model. In Aim 2 I will identify key cell populations responsible for generating
protection against subsequent infection by Streptococcus pneumoniae using flow cytometry and identify T-cell
receptor (TCR) motifs unique to polymicrobial infections using a newly developed TCR repertoire sequencing
strategy. Despite the several clinical observations made regarding the host immune response to co-infection,
many of these observations have not been explored mechanistically. I hypothesize that distinct genetic
determinants and host responses are operative during interspecies competitive models of colonization that
impact subsequent infection susceptibility.

Public health relevance
PROJECT NARRATIVE Despite the clear clinical significance of polymicrobial infections, the mechanistic factors and consequences of polymicrobial interactions during colonization of the upper respiratory tract remain poorly understood. In this proposal, I aim to 1) leverage functional genomics methods to determine how bacterial virulence networks are altered in the context of complex infectious colonization models, and 2) determine the effect of these colonization networks on cellular host responses following colonization through profiling of host mucosal responses. This research serves to identify the precise mechanisms underlying the poor clinical outcomes associated with bacterial co-infection.